Convergence of behavioral and sensory information in olfactory cortex

Project Summary
A key function of the nervous system is to transform sensory information from the environment into actionable
percepts. In a classic hierarchical representation framework, signals from peripheral receptor neurons with
simple tuning properties are transformed in primary sensory cortex to represent sensory objects. However,
recent data suggest that neural activity in primary sensory cortex strongly correlates with behavior, and that
sensory representations undergo large scale changes over time. We here test the hypotheses that behavioral
tuning of neurons in the olfactory (piriform) cortex supports the ability to filter out signals predicted by behavior,
and that coupling odor exposure to behavior stabilizes representational drift. Olfaction is an ideal model system
to study sensory-behavior interactions. Mice exhibit a rich repertoire of olfactory-driven behaviors, including
behaviors critical for survival and reproduction, and piriform cortex receives direct sensory inputs from the
olfactory bulb and is reciprocally interconnected with higher cognitive and motor areas.
We have implemented state-of-the-art experimental approaches to chronically record piriform neural activity
while synchronously monitoring behaviors. Our preliminary data suggests that sniffing, facial movements, and
locomotion can strongly modulate piriform neuronal activity.
Aim 1: To determine whether behavioral signals in piriform cortex subserve predictive processingWe
will combine two-photon calcium imaging in head-fixed mice with detailed behavioral monitoring of sniffing, facial
movements including whisking, and locomotion, and we will quantify the extent to which piriform odor responses
differ across spontaneously occurring behavioral states. We will then use a closed-loop experimental design to
directly test whether behavioral signals in piriform cortex serve to filter out expected sensory information. We
predict that neuronal responses to behaviorally coupled odors will decrease over time, while responses to
behaviorally uncoupled odors will remain unaltered. Aim 2: To determine whether representational drift in
piriform cortex is explained by behavioral change. We will quantify the stability of odor representations in
piriform cortex, and we will test the extent to which changes in odor tuning (representational drift) can be
explained by changes in behavioral state. We predict that representations of odors that consistently occur during
defined behavioral states remain stable over time, while responses to behaviorally uncoupled odors will drift.
Successful completion of the proposed project will provide new insight into how animal behavior shapes olfactory
processing and the generation of odor representations in the mammalian cortex. Our studies will set the stage
for future projects aimed at characterizing the neural circuit mechanisms underlying complex odor-behavior
representations in the olfactory cortex, and the investigation of complex olfactory-driven behaviors in freely
moving mice in naturalistic environments.

Public health relevance
Project Narrative The veridical representation of odor information in the olfactory cortex is challenged by behavioral signals and representational drift. Using in vivo two-photon microscopy, behavioral monitoring and closed-loop manipulations, we seek to understand the functional role of behavioral signals in odor processing. Completion of this study will open up new avenues of inquiry into the selective manipulation of neural circuit components underlying olfactory sensory-motor transformations during active sensing.